Stress, Mindfulness, and People with Intellectual Disabilities

Project Summary
Individuals with intellectual disabilities (ID) commonly experience high levels of
stress due to factors like social exclusion, bullying, limited support networks, and
discrimination. Because of this they are at risk for mental health difficulties like
depression, anxiety, and severe behavior problems. Mindfulness-based cognitive therapy
(MBCT) is increasingly being used for stress management for the general public and has
been successfully adapted to meet the unique learning needs of individuals with I.D.
However, there is a definite lack of home-based online mindfulness interventions
tailored to the unique learning needs of this population.
The central goal of this project is to create an online, interactive mindfulness-
based stress reduction program: Stress, Mindfulness, and People with Intellectual
Disabilities (SM-ID). We propose three Specific Aims with the primary aim of evaluating
the feasibility of the program by examining 30 used dyads (person with ID and a support
person) with an emphasis on program satisfaction and acceptability. One secondary aim
is to conduct formative research with key stakeholders (two focus groups) to aid in
identifying appropriate content and barriers to implementation. The other secondary
aim is to assess usability of the online program with 5 dyads. This work is significant
because it will provide resources for an underserved population – individuals with ID --
who experience frequent stress with the challenges of community living and who may
lack healthy coping capacities. Moreover, the proposed program has the potential to
broadly impact the way supports are delivered to individuals with ID by adding an
integrated, efficacious intervention that overcomes common barriers to individuals with
ID’s participation (time, finances, and availability). From a public health perspective,
this approach is ideally structured to meet the needs of this population of people with ID
who are in need of easy to implement and cost-effective support and training.
Upon completion in Phase II, individuals with ID and their support person will
have access to a complete SM-ID program, designed to help them cope with stress more
effectively and strengthen their healthy coping skills. The program will provide
individuals with ID with engaging, interactive content, including: tools for monitoring
progress, text prompts to motivate behavior change, guidance in setting effective value-
based goals, strategies for reducing stress, and training in mindfulness-based coping
skills. The SM-ID program will be available on a mobile website that can be accessed by
smart phones, tablets and computers and will provide realistic situational videos
vignettes, and workbook exercises to help individuals with ID deal effectively with stress.
In Phase I of this project, we will determine the feasibility of the program by examining
primary and secondary outcomes related to a prototype of the SM-ID program.

Public health relevance
Project Narrative There are no currently available mindfulness-based stress reduction interventions specifically tailored for adults with intellectual disabilities (ID). And, while there are a number of efficacious mindfulness-based stress management interventions for the general population, these approaches have significant limitations for use by people with ID – in that they do not address this populations unique learning needs. There is a need for an adapted approach giving individuals with ID low cost, immediate access to the help and support they need. This project addresses a significant public health need by developing and evaluating a low-cost, accessible online integrated mindfulness-based stress reduction program that can be easily implemented by individuals in this population with the support of their care providers to reduce their stress and strengthen their healthy coping skills.